ICEMR-Mali : Multidisciplinary research for malaria control and prevention in West Africa

SUMMARY
Wide deployment of malaria control tools in the past decade has significantly contributed to substantial
reduction of the incidence and deaths related to the disease in Sub-Sahara Africa.. Yet, the region continues to
carry a disproportionately high share of the global malaria burden of malaria deaths. Moreover, incidence
remains high but stable in some settings while rebounding in others after a long period of decrease associated
with intensive deployment of malaria control tools. The Overall goal of this ICEMR is to understand the variable
effectiveness of current malaria control interventions in different ecological settings of West Africa through
research to understand interactions between the parasite (response to drug treatment, genotypes, gametocyte
survival), human (immune response and host genetics) and the vector (ecology, behaviors, and response to
insecticides) and regulating influences of the local environment and human behavior. This ICEMR
encompasses 3 Projects with the goals summarized as follow: 1] Epidemiology Project (Project 1): The goal is
to understand why different patterns of malaria epidemiology and endemicity are resilient to current control
strategies at four sites in Mali, representing different eco-zones across West Africa, 2] Malaria immuno-
genomics Project (Project 2): The goal of this project is to identify genetic variation in the malaria parasite and
human host, and assess the impact of these differences on malaria transmission and effectiveness of malaria
control measures in four sites of Mali , 3] Malaria vector and transmission field ecology project (Project 3): The
project goal is to investigate important neglected aspects of malaria vector and transmission field ecology at
four sites in Mali, representing three eco-zones across West Africa. These projects links the different aspects
of malaria transmission and disease into a unified whole, adding the ability to distinguish the contributions of
different malaria control interventions on parasite population and range of immune responses (Project 2,
Immunopahtogenesis) and seasonal and geographical distribution of anopheline mosquitoes vectors (Project
3). Understanding the factors relating entomological and epidemiological patterns of transmission will provide
more definitive guidelines for malaria control efforts in Mali and in West Africa.

Public health relevance
RELEVANCE This proposal is directly relevant to public health because malaria remains a major life threatening disease across the globe, particularly among children less than 5 years of age and pregnant women in sub-Saharan Africa. This field-based malaria and vector epidemiology research will contribute not only to provide plausible evidence of the impact and relevance of combinations of malaria control strategies, but also allow to the development of more effective strategies to reduce malaria transmission in Africa.